Research and Education Core

The overarching goal of the Research and Education Core (REC) of the proposed Michigan Center on
Contextual Factors in Alzheimer's Disease (MCCFAD) is to enhance diversity in the professional research
workforce addressing the brain and cognitive health of older adults. REC is central to the proposed AD-
RCMAR because it will directly educate, mentor, and support junior and mid-career investigators from
underrepresented groups. Enhanced diversity in the professional research workforce who study the brain and
cognitive health of older adults is critical to advancing knowledge about and improving the care of older adults
in the U.S. In particular, REC synergy with the Administrative, Analytic and Community Liaison and
Recruitment Cores will be instrumental in achieving these aims, as will collaborations with rich resources
available at UM including NIA Centers, Inter-Consortium for Political and Social Research, the Health and
Retirement Study (HRS), and links to resources at Michigan State University and Wayne State University. REC
specific aims include the following: Aim 1: Support pilot studies for AD-RCMAR Scientists (RS) in ADRD
epidemiology, health economics, and culturally-sensitive care. Aim 2: Provide continuing mentoring activity for
AD-RCMAR Scientists (RS) to achieve independent investigator status; Aim 3: Offer education in ADRD Health
Disparities and minority aging research. Aim 4: Evaluate REC activities. Expert mentorship in health
disparities and minority aging research will primarily be provided to AD-RCMAR Scientists through an
individualized, integrative mentoring team, a monthly seminar series, and a yearly Summer Data Immersion.
Moreover, AD-RCMAR Scientist mentoring activities will continue beyond their funded year. We have designed
a unique and exceptional educational experience that will increase the workforce composed of and interested
in contextual factors related to ADRD. A team of expert faculty will guide these activities. The impact of the
REC is expected to be broad because we have designed activities to target and benefit not only funded AD-
RCMAR Scientists (e.g., integrative mentoring team; monthly seminar series), but also national researchers
(e.g., Summer Data Immersion) and the larger scientific community as a whole (e.g., peer-reviewed
publications and professional workshops on the responsible conduct of research with Arab American and
Latino populations).